Design principles and dynamic gene control in embryonic development

PROJECT SUMMARY
Elucidating the mechanism of transcriptional regulation is a complex multivariate problem that requires holistic
characterization of all transcriptional machinery including multiple enhancers, promoters, and other
architectural proteins. In particular, the development of groundbreaking “seq” techniques has significantly
advanced the field by providing a genome-wide frequency of enhancer-promoter interactions and related levels
of gene activity. Nevertheless, a critical gap remains because most available genome-wide data lack the
temporal and single-cell information needed to grasp the intricate interactions of enhancers and promoters in
individual cells. The “average” behavior from a population of cells does not capture the highly variable genome
topology that each cell exhibits, nor does a stochastic gene expression stemming from a specific enhancer-
promoter interaction. To discern how stochastic transcriptional activity contributes to deterministic
developmental processes, there is a critical need to decipher the regulatory logic governing enhancer-promoter
dynamics at the single-cell level. Our long-term goal is to identify design principles for precise gene control in
embryonic development, using a combination of quantitative live imaging, genetic perturbations, and
mathematical modeling. The overall objective of this proposal is to determine regulatory principles underlying
enhancer-promoter dynamics that govern transcriptional processes to ensure normal development. Beyond
matching an enhancer sequence with the target promoter, we will determine the extent to which a linear
enhancer-promoter distance and enhancer’s relative orientation to the promoter impacts the target gene
expression and subsequent development for short- and intermediate-range enhancer-promoter interactions.
For long-range enhancer-promoter interactions, the functional role of insulator-mediated chromatin looping
dynamics on transcriptional stochasticity and developmental robustness will be investigated. Lastly, we will
determine the differences in regulatory logic governing multi-enhancer-promoter interactions as compared to
one-on-one enhancer-promoter interactions. Since the mechanism of transcriptional regulation is conserved
across species, the successful completion of our projects will reveal another layer of gene control underlying
the development and diseases of multicellular eukaryotes.

Public health relevance
PROJECT NARRATIVE Disruptions in enhancers' interactions with target promoters often lead to diseases and developmental phenotypes, highlighting the need to identify design principles for proper gene control. We propose to control the dynamics of enhancer-promoter interactions by perturbing i) relative enhancer-promoter positioning, ii) insulators that mediate chromatin looping, and iii) enhancer-enhancer and promoter-promoter competitions. Utilizing quantitative, single-cell resolution live imaging, along with systematic genetic perturbations and mathematical modeling, we aim to unravel the structure-function relationships governing enhancer-promoter arrangements and transcription for normal development.